Resource

Abstract (Resource)
The Rat Resource and Research Center (RRRC) provides a unique and essential repository service to the
research community by importing, storing and distributing a large number of rat strains and embryonic stem cell
lines. It assures that valuable models are preserved and made available to interested investigators, allows
researchers to satisfy NIH requirements for resource sharing, relieves individual investigators from the burden
of animal distribution and ensures that models are maintained with rigorous genetic quality control and health
monitoring standards to enhance experimental reproducibility. Our objective during the next funding period is to
continue to improve and expand the functions and capabilities of the RRRC to provide biomedical investigators
with the rat models, embryonic stem cells, related reagents, protocols and services that will facilitate their
research. We will accomplish this by developing new and utilizing existing technologies to improve the quality
of the resource’s acquisition, cryopreservation, storage, quality control, and distribution of rats, sperm, embryos
and embryonic stem cells. We will continue to evaluate and improve our service delivery and our communication
with the biomedical research community. We will expand our services which already include re-derivation, colony
management, a wide array of genetic analysis options, model creation using CRISPR/Cas9 technology, and
microbiota characterization on a fee-for-service basis. In this way, the RRRC will strengthen its ability to serve
as a much-needed “one stop” resource for investigators using rats in biomedical research.